Administrative Core

PROJECT SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The CePCHE Administrative Core (AC) will consist of 5 components: (1) administration and
finances, (2) monitoring and evaluation, (3) External Advisory Committee (EAC), (4) Internal
Advisory Committee (IAC), and (5) training and Outreach/In-Reach. The AC will provide an
independent administrative structure to support Research Project Leaders (RPLs), and future
investigators, promoting a streamlined administrative process, reducing redundancies, costs,
and facilitating access to comprehensive Core services. An independent evaluation group will
monitor the progress of the CePCHE leadership, the RPLs, pipeline investigators, pilot projects
and mentors, and will report findings to the PIs, IAC and the EAC. This systematic assessment
since year 1 will permit monitor the milestones related to RPLs success in completing their
proposed research and transitioning to R01-level funding within three years of the start date of
this award.
This Core will engage RPLs with top scientists from across the country (EAC), who,
along with the IAC will work collaboratively to review the quality and progress of the RPLs.
Specific aims of the AC include: (1) Provide organizational leadership and administrative
structure for the successful completion of the proposed CePCHE program goals, leading to a
Phase II COBRE, (2) Effectively mentor early-career faculty in conducting cancer research,
preparing competitive research grant applications, and promoting independent funding, (3)
Conduct a sustainable long-term faculty development training program for the RPLs program
and pilot projects training for cancer research, with a special emphasis on identifying and
growing additional junior investigators with the capacity and commitment to successfully
conduct high-quality research, using CePCHE resources, including the Bioinformatics and
Biostatistics Core (BBC) services and its data repository, to support their emergence as
scientifically independent, R-level funded investigators and (3) Pursue innovative initiatives that
support the recruitment and career development of outstanding investigators who are well
positioned to respond to funding opportunities that span the spectrum of cancer research.
CePCHE will increase the portfolio of faculty invested in cancer research and move UPR toward
its long-term goal of securing additional cancer focused COBRE and ultimately achieve
designation as an NCI Comprehensive Cancer Center within 10 years. This long-term CePCHE
milestone, supported by a robust AC, will increase the diversity of the
workforce at the UPR
disparities
cancer research
by building a more inclusive and equitable community addressing cancer
and health equity.